A role for mitochondrial AMPK signaling in neurons

Project Summary
An early hallmark of Alzheimer’s Disease (AD) is a loss of neuronal connectivity reflected by decreased
dendritic spine densities in the hippocampus and cortex. Coinciding with this synaptic loss, both human
Alzheimer’s Disease patients and Alzheimer’s Disease animal models display a fragmented mitochondrial
phenotype. Our recent work demonstrated that Alzheimer’s induced mitochondrial fragmentation occurs as a
result of the overactivation of the CAMKK2-AMPK-MFF pathway. Excitingly, preventing AMPK-mediated
activation of MFF not only blocked mitochondrial fragmentation but also ablated spine loss arguing for a casual
link between mitochondrial loss and spine maintenance. Thus, the goal of this proposal is to determine how
AMPK governs mitochondrial morphology and function to coordinate spine maintenance in vivo. This topic is
especially relevant as repeated activation of AMPK, by drugs such as metformin, is being considered as an
intervention for both normal aging and Alzheimer’s Disease. Interestingly, up to twelve unique AMPK
complexes can exists, and recent work has shown that different complexes can have distinct activation
kinetics, substrates and subcellular localizations including at the mitochondrial surface (mitoAMPK). Our
overall hypotheses are that prolonged activation of mitoAMPK drives dendritic mitochondrial fragmentation and
removal inducing spine loss, and that targeted ablation of AMPK at the mitochondrial surface is sufficient to
rescue Aβ42-induced spine loss. The focus of Aim 1 is to determine the molecular composition and cellular
dynamics of mitoAMPK in wildtype and AD neurons by using biochemical, Crispr/Cas9 knock-in and kinetic
proteomics techniques. Aim 2 will establish the role of mitoAMPK activity for dendritic structure and function by
using in vivo 2-photon microscopy and electrophysiology to determine mitoAMPK’s impact on dendrite
branching, spine dynamics, calcium handling and neuronal activity in both wildtype and AD mouse models. Aim
3 will interrogate the cellular consequences of long-term AMPK activation in hippocampal neurons. While
monitoring mitochondria and dendrite structure and function, we will genetically or pharmacologically activate
AMPK in both wildtype and AD mouse models. The proposed work will provide a greater understanding of the
mechanisms responsible for local AMPK activity in neurons, and potentially identify a distinct AMPK complex
targetable in neurodegeneration.

Public health relevance
Project Narrative The work in these studies will generate new knowledge of the role that AMPK activation plays in mitochondrial structure and function, and how it is linked to synaptic loss in Alzheimer’s Disease. As such, it is directly related to the NIH’s mission to enhance health and reduce illness.